Coupling gene regulation to flagellar morphogenesis

Project Abstract
The bacterial flagellum is essential for motility and virulence for Gram-negative pathogens. Flagellum assembly
is complex and coupled to the controlled expression of more than 70 genes in the flagellar and chemotaxis
regulon. It takes many cell generations to assemble a completed flagellum. For 30 years my lab has investigated
mechanisms that couple flagellar gene expression to assembly and the associated type III secretion (T3S)
system. T3S is the only secretion system in Biology that undergoes a secretion-substrate transition from one
class of secretion-substrates to another. One focus of this grant application is to determine the mechanism of
the secretion-specificity switch in flagellar and the related virulence-specific injectisome T3S systems. The
research will also determine how specific proteins are selected from the thousands present in the cytoplasm and
targeted for T3 secretion. We will also characterize key gaps in the understanding of how flagellar gene regulation
is coupled to assembly and how the entire flagellar regulon responds to global gene regulatory systems.

Public health relevance
Narrative T3S is arguably the most important route through which Gram-negative animal pathogens cause disease in humans. The characterization of the Salmonella flagellum assembly, T3S substrate targeting and coupled gene regulatory mechanisms will further our understanding of host-pathogen interactions, protein-secretion specificity, and nanomachine self-assembly. These complex mechanisms provide a wealth of potential antibiotic targets to inhibit T3S-associated pathogenesis.